Core A Admin Core

The Administrative Core (Core A) provides the leadership, organizational structure, planning, educational
opportunities and sound fiscal practices that propel CFAR investigators to achieve their highest scientific
potential through innovative, multidisciplinary research collaborations that is at the heart of the UAB CFAR
mission. The Administrative Core serves as the coordinating center for the entire UAB CFAR and is
responsible for the continuous monitoring, evaluation, and assessment of service provision to assure full
alignment with the strategic objectives of the Center. These critical functions are accomplished through high
level engagement of the CFAR leadership in the activities of the Center, including: Frequent and effective
communication with CFAR members, ongoing strategic planning, continuous monitoring of the effectiveness
and outcomes of services and activities, assessment of scientific developments in the HIV research
community, and alignment of existing scientific expertise and services at the UAB CFAR with these new
developments and the NIH priorities. The core strives to enhance diversity within the Center and the
development of early stage investigators to independence. Among the 45 new members recruited since the
last renewal, 65% are women, 25% are under-represented / ethnic minorities. Of the new grants on the UAB
funded research base this budget period, 38% were advanced with developmental pilot funding, demonstrating
an ongoing commitment to fostering independence. Through participation in strategic recruitments, pilot
funding and Interdisciplinary Research Groups (IRGs) / Scientific Working Groups (SWGs) the core enables
critical management tools to foster new, dynamic programs aligned with emerging trends in HIV research.
Since the last renewal, a cadre of 185 UAB HIV/AIDS investigators have been supported to work in a fully
collaborative and effective fashion, achieving over $66M in total HIV funding to the institution and supporting
over 1000 HIV publications. Leveraging a highly effectual administrative team, the core administrates several
nationwide NIH-funded HIV program projects based at UAB (e.g., the CFAR Network of Integrated Clinical
Systems (CNICS), the Creative and Novel Ideas in HIV Research (CNIHR), the HIV and Aging Pilot Program,
the Women’s Interagency HIV Study’s joint site between UAB and the University of Mississippi Medical Center
(WIHS), and the Alabama Clinical Trials Unit) recovering over $500,000 in salary support annually. Through
these ongoing efforts, the Core will contribute new knowledge and approaches to curb HIV transmission,
improve preventative, therapeutics and clinical outcomes, and have maximal impact on the global
consequences of HIV.